Optimizing and understanding semantic feature analysis treatment for aphasia: A randomized controlled comparative-effectiveness trial

This randomized comparative effectiveness trial examines whether active manipulation of a key component
of semantic feature analysis (SFA) treatment for word-finding difficulty in aphasia improves outcomes. The key
component in question is the number of semantic features that persons with aphasia are asked to generate on
each treatment trial. Study participants (n=40) will be recruited and randomized to receive either a many-
features version of SFA or a few-features version. In the many-features condition, participants will be asked to
generate 11 semantic features for each word practiced. Participants assigned to the few-features condition will
be asked to generate 5 features for each word practiced. The total treatment time will be equated in the two
conditions. Because each trial will take less time in the few-features condition, participants in this group will
cycle through the lists of treated items more often, providing them with more opportunities to practice the
phonological form of the targets, at the expense of more elaborated feature generation practice.
Correspondingly, the many-features group will receive more practice generating semantic features, at the
expense of few opportunities to practice the target word forms.
Study participants will be housed locally at the Pittsburgh site for five weeks during which they will receive
60 hours of SFA treatment with pre- and post-treatment assessment of their ability to name pictures of treated
and untreated, semantically related nouns. Other secondary outcomes, including measures of connected
speech and patient-reported communication ability will also be collected. In order to address unresolved
questions about the underlying cognitive and neural mechanisms of SFA, participants will also receive
concurrent pre- and post-treatment assessment of automatic word processing ability using eye-tracking
methods and functional magnetic resonance imaging (fMRI). Participants will also be asked to return to
Pittsburgh for one-month follow-up language, eye-tracking, and fMRI testing.
The language testing results will be used to determine the appropriate balance of feature generation
practice vs. word form practice to optimize SFA outcomes. The eye-tracking results will be used to infer
whether SFA’s positive effects can be attributed to improved activation of lexical-semantic representations,
improved ability to inhibit competing representations, or both. The fMRI results will be used to identify the
brain networks and activation changes associated with changes in naming ability resulting from SFA. This
study will provide theoretically and clinically relevant information about how aphasia treatment should be
delivered and the neurocognitive mechanisms underlying its effects.

Public health relevance
This randomized controlled comparative effectiveness study examines manipulation of a key component of an established and efficacious treatment for naming impairments in aphasia, along with cognitive and brain correlates of treatment success. Study participants will be randomly assigned to one of two treatment conditions emphasizing practice of either word meanings or word forms. Their performance on standardized and study-specific measures will be used to determine which version of the treatment provides superior outcomes, and measures of automatic language processing and functional brain imaging will also be used to identify the underlying neurocognitive mechanisms associated with positive treatment response.